The Impact of Depression and Preclinical Alzheimer Disease on Driving Among Older Adults

PROJECT SUMMARY/ABSTRACT
Our long-term goal is to accurately identify who is at risk of decline in driving, to forecast when decline
will occur, and to intervene before decline, thereby reducing the numbers of crashes, injuries, and death in
older adults. Our findings indicate that the long preclinical stage of Alzheimer disease (AD), as reflected in
amyloid imaging and cerebrospinal fluid (CSF) biomarkers among cognitively normal persons, is associated
with poorer driving performance on a standardized road test. This project will assess how depression,
preclinical AD, and antidepressants affect driving behavior in cognitively normal older adults (≥ 65 years).
This research is significant because 36 million licensed drivers are aged 65 years or older, and the
number of older adults in the United States is expected to double by 2050, when 1 in 4 drivers will be 65 years
or older. Motor vehicle crashes are a leading cause of injury and death in older adults (814 daily crashes).
Driving is a cognitively demanding and highly dynamic activity. Depression and symptomatic AD independently
increase the risk of an automobile crash. Depression is also a factor for conversion to symptomatic AD, yet it is
often used as an exclusion criterion for aging studies. The adverse impact of depression and antidepressant
use on driving, and the impact of depression on AD is documented; yet an understanding of the synergy
between these three areas is lacking.
Our Specific Aims will (1) characterize the relationship between major depression (diagnosis) and
naturalistic driving behavior in a prospective, longitudinal study, (2) examine whether major depression and
preclinical AD, combined, predict faster longitudinal change in driving behavior among older adults, (3) assess
the impact of medications (antidepressants), major depression, and preclinical AD on naturalistic driving.
To test these Specific Aims, we have assembled a multidisciplinary team with expertise in AD,
depression, neuroimaging biomarkers, CSF biomarkers, naturalistic driving, cognitive and brain aging, and
longitudinal biostatistical methods. We will capitalize on existing infrastructure to follow 70 currently enrolled
individuals and enroll an additional 70 participants with depression, to create a cohort of 140 individuals. This
cohort will utilize a naturalistic driving methodology that will capture their driving behaviors on an everyday
basis. Their cognition will be tested annually using the Clinical Dementia Rating and various psychometric
measures. Participant depression will be characterized using the Mini-International Neuropsychiatric Interview
(MINI) and the 9-item Patient Health Questionnaire (PHQ-9).
Once obtained, this knowledge can be used to create stage-appropriate, personalized, driving-related
safety strategies that can be implemented upon diagnosis, and adjusted throughout disease progression.

Public health relevance
PROJECT NARRATIVE Our overall long-term goal is to accurately identify who is at risk of decline in driving, to forecast when decline will occur, and to intervene before decline, thereby reducing the numbers of crashes, injuries, and death in older adults. By 2050, 1 in 4 drivers will be 65 or more years of age, and currently, motor vehicle crashes are a leading cause of injury and death in older adults, with depression and symptomatic Alzheimer disease (AD) independently increasing the risk of a crash. Driving data continuously collected from the natural environment are needed to more accurately evaluate daily behavior and can allow us to determine how preclinical AD, depression, and antidepressant use affect driving decline and crash risk over time.